AhR activation in Th17 and Treg cell differentiation

DESCRIPTION (provided by applicant): Host detection of microbial pathogens triggers a chain of events that results in recruitment and differentiation of T lymphocytes with functions suited to restrain offending microorganisms. Th17 cells, a newly defined subset of CD4+ T helper cells, secrete signature cytokines interleukin (IL)-17A, IL-17F, and IL-22. Th17 cells have been shown to play an important role in maintenance of mucosal integrity and immunity. On the other hand, dysregulated Th17 responses result in autoimmunity both in mice and in humans. Another subset of CD4+ T cells, the regulatory T cells (Tregs), suppresses effector T cell responses and prevents their potentially pathogenic effects. The balance between Th17 and Treg cells is influenced by the local cytokine milieu and is achieved through the concerted action of transcription factors to maintain immune homeostasis. RORγt and Foxp3 have been shown to be the key transcription factors in specifying differentiation programs of Th17 and Treg lineages, respectively. Our recent data suggest that Th17 and Treg fate decision can be determined by the balance of RORγt and Foxp3, at least in part through physical interaction. Recently, it has been shown that the aryl hydrocarbon receptor (AhR), a ligand-dependent transcription factor best known to mediate the effects of environmental toxins (e.g. dioxin), is an important transcription factor in the Th17 lineage, especially for IL- 22 expression. AhR also regulates Foxp3 expression, thus likely influencing the balance of Th17 and Treg cell differentiation. However, little is known about the molecular mechanisms of action of AhR in these processes. The objective of this proposal is to examine how the interaction of transcription factors will impact Th17 and Treg cell differentiation and function. Proposed are experiments to investigate the interplay among AhR, RORγt, and Foxp3. A combination of biochemical, molecular, and genetic approaches will be employed to study the molecular action of AhR in determining Th17 cell differentiation program, the cross-regulation of AhR and Foxp3 during Th17 and Treg differentiation, and the functional significance of AhR activation in a ligand- independent and cell-type specific manner in vivo. These experiments will offer an exciting opportunity to provide fresh mechanistic insights into how AhR coordinates with RORγt and Foxp3 to program Th17 and Treg cell differentiation, and shed light on AhR function in modulating Th17 and Treg balance in the physiological steady state or during microbial infection. A better understanding of the mechanism by which AhR regulates Th17 and Treg cell differentiation will be informative toward the identification of new targets for treating human infectious and autoimmune diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Th17 and Treg cell balance plays a critical role in maintaining immune homeostasis. The proposed experiments will allow us to investigate how AhR influences Th17 and Treg cell differentiation through cooperative/antagonistic interaction with RORγt and Foxp3, and the function of AhR activation in vivo in a cell- type specific manner. Understanding the differentiation of Th17 and Treg cells at molecular levels will shed light on the disease pathogenesis and may eventually provide novel means for treating human infectious and autoimmune diseases. Project Narrative The Th17 and Treg cell balance plays a critical role in maintaining immune homeostasis. The proposed experiments will allow us to investigate how AhR influences Th17 and Treg cell differentiation through cooperative/antagonistic interaction with RORγt and Foxp3, and the function of AhR activation in vivo in a cell- type specific manner. Understanding the differentiation of Th17 and Treg cells at molecular levels will shed light on the disease pathogenesis and may eventually provide novel means for treating human infectious and autoimmune diseases. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Host detection of microbial pathogens triggers a chain of events that results in recruitment and differentiation of T lymphocytes with functions suited to restrain offending microorganisms. Th17 cells, a newly defined subset of T helper cells, secrete signature cytokines interleukin (IL)-17A (hereafter referred to as IL-17), IL-17F, and IL-22 (Langrish et al., 2005) (Harrington et al., 2005) (Park et al., 2005). Th17 cells have been shown to play an important role in maintenance of mucosal integrity and immunity (Mangan et al., 2006) (Zheng et al., 2008) (Aujla et al., 2008). On the other hand, dysregulated Th17 responses result in autoimmunity both in mice and in humans (Korn et al., 2009). Another subset of CD4+ T cells, the regulatory T cells (Tregs), suppresses effector T cell responses and prevents their potentially pathogenic effects. The balance between Th17 and Treg cells is influenced by the local cytokine milieu and is achieved through the concerted action of transcription factors to maintain immune homeostasis. RORγt and Foxp3 have been shown to be the key transcription factors in specifying differentiation programs of Th17 and Treg lineages, respectively (Ivanov et al., 2006) (Hori et al., 2003) (Fontenot et al., 2003). Our recent data suggest that Th17 and Treg fate decision can be determined by the balance of RORγt and Foxp3, at least in part through physical interaction (Zhou et al., 2008). Our long-term research goal is to dissect transcriptional regulatory networks that govern the Th17 cell differentiation and modulate the Th17 and Treg cell balance to maintain immune homeostasis. We now present preliminary evidence that: 1) the aryl hydrocarbon receptor (AhR), a ligand-dependent transcription factor best known to mediate the effects of environmental toxins, is one of the most upregulated transcription factors during Th17 cell polarization; 2) AhR and RORγt cooperatively upregulate Il17 and Il22 expression; 3) activation of AhR leads to downregulation of Foxp3 expression; 4) AhR physically interacts with Foxp3; and 5) Th17 cytokine expression is compromised in AhR-deficient animals, which are more susceptible to infection of Citrobacter rodentium, a well-characterized IL-22 dependent, Th17-mediated infection model. The impact of AhR activation on the immune system has been mainly evaluated based on the administration of AhR ligands into animals. However, most, if not all, cells of the immune system express AhR, and ligand administration will inevitably activate AhR in many cell types (e.g. the innate immune cells). Therefore, the effects of AhR by ligand activation on Th17 and Treg cell differentiation in vivo may not be T cell intrinsic. Based on these data, our central hypothesis is that AhR influences Th17 and Treg developmental decision by interaction with RORγt and/or Foxp3, and activation of AhR in vivo will modulate the Th17 and Treg balance. The rationale for the proposed research is that, once it is known about the role of AhR and its partners in determining Th17 and Treg cell differentiation, modulation of AhR activity will thus be possible to have an impact on immune homeostasis to prevent or treat a variety of diseases. We will test our central hypothesis by pursuing the following three specific aims: Aim 1: Study the molecular action of AhR in Th17 cell differentiation program. We will determine the signal(s) that induce AhR expression in Th17 cells, focusing on whether AhR is directly regulated by Stat3 and Smad proteins. We will also investigate whether Il22 and Il17 genes are direct targets of AhR and explore the possibility of facilitated binding of AhR to the cytokine gene loci by RORγt. Finally, we are going to examine whether the cooperativity between AhR and RORγt to induce Th17 cytokine genes is achieved at the chromatin level and/or through physical protein interaction. Aim 2: Study the cross-regulation of AhR and Foxp3 through protein interaction and/or expression during Treg and Th17 cell differentiation. We will characterize the interaction between AhR and Foxp3 in CD4+ T cells. We will also determine the mechanisms by which TGF-β inhibits AhR activity and functional consequences of the interaction between AhR/RORγt and Foxp3. Finally, we will induce deletion of a conditional Ahr allele in Foxp3+ Treg cells to examine the Th17 and Treg balance in vivo. Aim 3: Study the function of AhR by cell type-specific expression of a constitutively active Ahr allele in vivo. We have developed a constitutively active AhR protein (CA-AhR) and showed that it induces Il22 expression when expressed in T cells without ligand. Using this system, we will generate a new mouse model in which CA-AhR is inducibly expressed in a ligand-independent and cell type-specific manner (Ahrstop-Flag CA-AhR-IRES-GFP mice). We will examine the in vivo role of AhR activation in T cells (e.g. Tregs) under the physiological steady state or during pathogenic infection. Collectively, our proposed studies will provide unprecedented insight into the molecular mechanisms by which the Th17 and Treg balance is achieved and allow us to examine the impact of AhR activation directly in vivo in a cell-intrinsic manner. The knowledge gained from our studies may eventually provide novel means for treating human infectious and autoimmune diseases.